CRISPR interference to identify HSA21 genes reducing neurogenesis

Down syndrome (DS) is caused by complete or partial trisomy of human chromosome 21 (Hsa21). It comprises
a complex phenotype of over 80 features including metabolic dysregulation and a marked reduction in both
neurogenesis and brain size. The speciﬁc molecular mechanisms by which trisomy of Hsa21 gives rise to DS
pathologies remain unknown. Identifying the dominant genes or molecular pathways involved would open the
possibility for developing targeted therapies to improve the lives of affected individuals. Here, we propose
combining CRISPR interference (CRISPRi) technology with induced pluripotent stem cells (iPSCs) derived from
individuals with DS (3S-iPSCs) to develop a selectable screen for Hsa21 genes that contribute to DS pathologies.
The complexity of the DS phenotype has been a roadblock to deﬁnitive identiﬁcation of genes that play prominent
roles in the syndrome. Our preliminary data show evidence of two important, fundamental differences between
DS cells and isogenic, euploid controls that can be detected and quantiﬁed at the single-cell level, thereby
opening the door widely for the development of high through-put screens for gene identiﬁcation. One of these
key differences, elevated mitochondrial membrane potential (∆ψm), is evident in 3S-iPSCs in the pluripotent state;
the other, reduced ability to commitment to a neuroectodermal (NE) lineage, is directly relevant to what is
arguably the most prominent feature of DS, that of intellectual disability. The goal of this R21 proposal is to build
the tools necessary to carry out CRISPRi-based, high throughput screens to identify genes on Hsa21 that
contribute to DS pathologies at the earliest stages of development. Aim 1 will use TALEN-nuclease directed
editing to integrate a transgene expressing dCAS9-KRAB into a safe-harbor locus in 3S-iPSCs. Aim 2 will focus
on designing guide RNAs that achieve graded repression to more closely model a reduction in gene dosage
from the trisomic three copies to the normal two copies.
Successful completion of our proposed studies will provide proof-of-concept for our approach to functional gene
identiﬁcation in DS and lay the foundation for expanding to comprehensive and combinatorial screens of the full
coding and non-coding content of Hsa21. It will also make a powerful and ﬂexible tool available to the DS
research community due to the totipotency of iPSCs.

Public health relevance
Project Narrative The goal of this proposal is to develop a genetic screen in single cells with selectable markers that can be used for high through-put, unbiased identification of genes, or combinations of genes, on human chromosome 21 that contribute to Down syndrome pathologies at the earliest stages of development.